Task C19: Efficacy of amoxicillin and amoxicillin/clavulanate in NHP model of anthrax

This contract provides for the development and standardization of non-human primate models for infectious diseases, and may include efficacy testing of candidate products, including GLP studies to support licensure.